Impact of sex on respiratory response to wood smoke exposure

PROJECT SUMMARY / ABSTRACT
This career development proposal is focused on acquiring the necessary technical research and professional
skills to establish an independent extramurally funded research program focused on investigating sex specific
effects of air pollutants on respiratory health. This work builds on my current research, which focuses on the
effects of air pollutants such as wood smoke, ozone, tobacco products, and e-cigarettes on the upper airway,
specifically in the nasal mucosa. This TIEHR career development award will broaden my technical research
skills and build needed expertise in lower airway assessment to effectively establish my independent career as
an inhalation toxicologist.
The research proposed in this grant is designed to test the central hypothesis that that genetic and hormonal
sex mediate respiratory immune responses to wood smoke exposure. The aims of this grant include: 1)
determining sex specific pulmonary physiology and immune effects of wood smoke exposure in vivo and 2)
evaluating ex vivo interactive effects of wood smoke and sex hormone manipulation on primary lung epithelial
and macrophage cell cultures. Data generated by the completion of this grant will fill a large gap in knowledge
and understanding of sex specific respiratory responses to air pollutant exposure, specifically to wood smoke.
It will also begin identifying mechanisms of genetic and hormonal regulation of immune response in the airway.
More globally, this work will provide new targets of exploration for preventative or treatment measures against
adverse responses to air pollutants.
To complete my training, this grant unites multiple experts to synergistically support the goals of research and
career training. The aims are designed to achieve training in: 1) clinical studies, 2) respiratory function
assessment, 3) wood smoke chemical characterization, 4) lower airway sampling and sample analysis
techniques, and 5) genomic analysis pipelines, in order to determine comprehensive effects of wood smoke
exposure on the lower airway. This training will enhance my ability to systematically investigate sex-specific
regulation of the immune system and responses to air pollutant exposure in human clinical studies. Training in
each area will be provided by experts in their respective fields. Additionally, laboratory management,
grantsmanship, scientific communication, mentorship, and career development skills will be attained through
workshops, presentations, and other hands on training. Upon successful completion of the training portion of
this grant, it is expected that I will be successful as an independent investigator and prepared to establish a
R01 funded research program.

Public health relevance
PROJECT NARRATIVE This career development award is focused on developing the necessary skills, through mentored training, to independently investigate sex specific effects of air pollutants on respiratory health. This project will significantly enhance understanding of sex specific regulation of respiratory immune function in response to wood smoke exposure using in vivo and translational models with immediate human relevance. Increasing our understanding of differential respiratory immune responses in males and females to air pollutants will potentially identify new targets for preventative measure development or treatments against adverse responses and will decrease the burden on public health.